Scaling Out and Scaling Up the Systems Analysis and Improvement Approach to Optimize the Hypertension Diagnosis andCare Cascade for HIV-infected Individuals (SCALE SAIA HTN)

Undiagnosed and untreated hypertension (HTN) is a main driver of cardiovascular disease, contributing to
a third of deaths globally, disproportionately affecting low and middle-income countries. Across sSA, country-
level application of evidence-based guidelines to screen and manage HTN is low and variable due to lack of
service readiness, uneven health worker motivation, weak health worker accountability systems, and poor
integration of HTN screening and management with chronic care services. In Mozambique, where HIV
prevalence is >13%, the HIV treatment platform is the only scaled chronic care service. With over 900,000
patients on anti-retroviral therapy, it presents an opportunity to standardize and scale HTN care cascade
services. Low-cost, systems-level strategies are effective in improving linked cascade services and may be
effective for routinizing HTN diagnosis and management within existing HIV services; improving flow through
the HTN cascade; and improving patient-level outcomes.
Our proposal builds on the ongoing SAIA-HTN trial. The overall objective of our UG3/UH3 (SCALE SAIA-
HTN) is to establish a robust evidence base on the effectiveness of a multi-component implementation strategy
(SAIA) on the HTN/HIV cascade using a ‘scaling-out’ framework, whereby strength can be ‘borrowed’ from
prior effectiveness trials. SCALE SAIA-HTN will be ‘scaled out’ through a novel modality delivered by district
health supervisors (rather than study nurses). We will also ‘scale up’ SAIA-HTN by expanding to all districts in
two additional provinces (15 districts), serving as a foundation for national scale-up. We propose three aims for
the UG3 (Planning) and two for UH3 (Implementation) phases. UG3-Aim 1: To develop a multi-sectoral
partnership of key stakeholders and establish HTN technical working groups at the national level and with
participating provinces. UG3-Aim 2: To identify key facilitators and barriers that could affect the adoption,
integration, scale-up and sustainment of the SAIA-HTN implementation strategy. UG3-Aim 3: To conduct a
pilot study to assess feasibility and acceptability of the district supervisor-led SAIA-HTN intervention over six
months in one primary care facility and redesign tools and standard operating procedures as necessary for the
UH3 phase. UH3-Aim 1: Develop a district-based dissemination and implementation strategy for SCALE SAIA-
HTN using the RE-AIM model to evaluate the programs’ Reach, Effectiveness, Adoption, Implementation and
Maintenance. UH3-Aim 2: Determine the costs of SCALE SAIA-HTN for care cascade optimization. We will
estimate total incremental and unit costs of integrating HTN diagnosis and management into HIV care.

Public health relevance
Project Narrative This application will develop a dissemination and implementation model for the evidence-based Systems Analysis and Improvement Approach (SAIA) for the delivery of hypertension care for PLHIV that is delivered by district MOH supervisors (rather than research nurses), to serve as a foundation for national scaling in Mozambique. .